Genetic Associations of Ischemic Heart Disease and Symptoms Among Diverse Postmenopausal Women

Project Summary/Abstract
Ischemic heart disease (IHD) is the most common cause of global mortality. Women in the U.S. are more
likely than men to report “atypical” symptoms of IHD, have a mis- or undiagnosed heart attack, and experience
delayed cardiac treatment. Current screening, diagnostic, and intervention protocols are based on research
focused primarily on symptoms and physiologic profiles in men of European ancestry. As a result, women
experience significant healthcare disparities related to major adverse cardiac events (MACE), including
myocardial infarction, stroke, and death. The incidence of IHD and MACE in women is highest during the
postmenopausal (post-MP) phase, when it surpasses that of age-matched men. Known risk factors fail to fully
explain these sex-based IHD disparities. Genetic variation between the sexes has been implicated as a major
reason for symptom and outcome differences, preceding all other known cardiac risk factors. Its mechanisms,
however, are poorly understood. Women with African American (AA) ancestry and Hispanic women are at
greater risk of poor outcomes, yet even less is known about their genetic risk factors.
The PI has identified RAP1GAP2 as a strong candidate gene for sex-associated effects on women’s IHD
outcomes. Her preliminary studies demonstrate 1) associations between certain RAP1GAP2 markers and IHD
case status and mortality among women but not men, with variations in ancestry-specific alleles; and 2)
trends in gene-expression differences by sex, IHD, and platelet activity. RAP1GAP2 is a major contributor to
platelet activation. Platelet activity is an independent risk factor for heart disease, linking clotting with IHD
development. The next logical step in this work is to fill in missing gene marker data across the full RAP1GAP2
gene in high-risk women, identifying causal associations with IHD outcomes (aka, gene fine-mapping) while
accounting for genomic ancestry variation. This will poise our team for studies of mechanism and clinical
application.
The purpose of this R21 is to determine RAP1GAP2 causal gene markers indicative of female-associated
cardiac health risks (Aim 1—time to first MACE occurrence; Aim 2—presence of “atypical” IHD symptoms)
and test ancestry-moderation of gene effects on outcomes (Aim 3) using novel and rigorous statistical
genetics methods. Our research team will harness existing biorepository data from three all-female cardiac
studies that examined more than 17,000 post-MP women in the U.S. Guided by the NIH’s sex-as-a-
biological-variable framework and symptom science model, we designed this study to address often-cited
research limitations of statistical power and diversity. Rather than relying solely on social constructs of race, we
will incorporate genomic ancestry markers to achieve Aims 1 and 2. Results will fill evidentiary gaps in the
genetics underlying women’s IHD. Findings could lead to improved sex-based IHD evaluation, treatment, and
outcomes for women, thereby reducing cardiac health disparities.

Public health relevance
Project Narrative Ischemic heart disease (IHD) is the leading global killer, with postmenopausal women in the U.S. at higher risk than age-matched men for IHD-related events like heart attack, stroke, and death. This project will study how markers in a gene that regulates platelet activity affect IHD symptoms and major cardiac events in postmenopausal women from different racial and ethnic groups (European American, African American, Hispanic). Study findings could improve IHD assessment and treatment for women and significantly reduce sex- and race-associated cardiac health disparities.